Data Core

Mount Sinai ADRC (Sano): Data Core (Core C) – Research Summary
The Data Management and Statistics Core (Data Core) leverages our specific expertise to provide
integrated, state-of-the-art data management and statistical analysis and infrastructure support
for the Mount Sinai Alzheimer's Disease Research Center (MSADRC) and affiliated research
studies. The Data Core provides informatics expertise and assistance, including timely data
transmission to NACC and query and reporting support to all MSADRC Cores. The Data Core is
poised to exploit local data resources, including Mount Sinai and VA electronic health records,
national resources, such as NACC, and external data sources, such as data from large,
administrative data sources to support exploration of MSADRC's thematic emphasis on
understanding disease heterogeneity and resilience. We are deeply committed to methodological
research in dementia, and have long track records and strong commitments to training dementia
researchers in data management and statistical methods. The Data Core is an essential
component of the MSADRC as we facilitate scientific rigor, regulatory-compliance and strong
connectedness across all cores within our ADRC, with NACC, other ADRCs, and other research
initiatives Alzheimer's disease and other degenerative diseases nationwide. We plan to continue
our work in all of these areas, which are well aligned with priorities highlighted in the RFA. Our
Specific Aims are: 1: To continue to provide a reliable, quality assured and secure data ecosystem
to support all ADRC cores. 2: To continue to provide integrated statistical analysis and
infrastructure support solutions for ADRC Cores. 3: To continue to provide education opportunities
to ADRC investigators, trainees, and junior faculty in data management, quality assurance, and
statistical analysis methods. 4: To broaden our impact by increasing the Findability, Accessibility,
Interoperability and Reusability (FAIR) of our unique data. We will accelerate AD research and
translation by leveraging both our extensive experience with ADRC data and modern data science
approaches. Our planned data modernization and adherence to the FAIR principles will help to
extend the impact of our unique, diverse data maximally for the broader research and translation
community.